Developing IVY: A Virtual Intervention for Victimized Youth

Project Summary
Overview: The overarching goal of this project is to finalize the development of and conduct a
pilot study for a novel intervention (i.e., Intervention for Victimized Youth (IVY)) to reduce
distress and increase coping skills for targets of peer victimization. IVY is the first small group
intervention program to specifically address the needs of targets of peer victimization from a
trauma-informed perspective. It uses a cognitive behavioral therapy approach to address
current distress and teaches strategies for handling future peer victimization.
Significance of the Proposed Research: Despite the large amount of research on peer
victimization, there is no intervention specifically designed for youth who are victimized by
peers. Most programs focus on reducing and preventing peer victimization, not on what to do for
those still being victimized. IVY is designed to fill this gap and provide practitioners with a
curriculum for delivering a high-quality intervention for this group of youth that has been ignored.
Innovation and Unique Features of the Proposed Research: Not only is IVY the first small
group intervention program for victimized youth, but it is delivered in a virtual format. The benefit
of virtual groups is that it allows youth from different schools to come together to discuss shared
experiences without fear that what they say will be shared with peers at school or without
worrying that a bully from their own school is in the group. IVY is also unique in that it is inspired
by the empirical literature on trauma, which aligns with the emerging view that peer victimization
is a potentially traumatic event.
Specific Aims: (1) Develop IVY, a trauma-informed peer victimization intervention program,
including a leader handbook, participant handbook, presentation slides, relevant activities and
resources, fidelity checklist, and a caregiver module; and (2) Investigate the usability, fidelity,
and effectiveness of IVY in a pilot study to assess the impact of the intervention components on
immediate outcomes (i.e., distress, coping skills, knowledge of and self-efficacy for self-
protection options), and distal outcomes (i.e., victimization, traumatic stress, social support).
Research Design and Methods: The pilot study includes a quasi-experimental/pre-post
intervention design with random assignment to an intervention group and a waitlist control group
with a total of 50 middle school students. Changes in the proximal and distal outcome variables
for the experimental and control conditions will be explored. A repeated measures MANCOVA
will be used to assess changes in pre- and post- scores.

Public health relevance
Project Narrative Each year, more than 20% of children and adolescents are targets of frequent peer victimization, and most suffer social, emotional, and academic difficulties as a result. Despite the prevalence of peer victimization, there are no specialized small group counseling interventions specifically designed to meet the needs of these youth. The focus of the current project is to develop and test a virtual group intervention that is informed by the trauma intervention literature.